Systematic identification of RNA sequences and protein components regulating circular RNA translation

PROJECT SUMMARY
The human genome encodes tens of thousands of circRNAs, of which the translation is essential for
regulating important biological functions, such as cell proliferation, differentiation, and migration. Interference
with circRNA translation can lead to tumorigenesis and metastasis of cancers. It is unclear, however, how
disrupting circRNA translation can cause the diseases. Identifying the regulatory components of circRNA
translation can provide valuable clinical insights. However, current technologies cannot distinguish circRNAs
from linear RNAs efficiently, such that the mechanism and molecular components regulating circRNA translation
remain unclear. Thus, it is imperative to develop a technology that can identify the components regulating
circRNA translation with higher sensitivity and specificity.
I have developed a high-throughput reporter screening assay that can systematically screen and identify
the RNA sequences that initiate circRNA translation specifically. Utilizing the technology, I discovered two groups
of the RNA sequences that specifically drive translation on either circRNA or linear RNA, respectively, indicating
that the regulatory components between linear RNA and circRNA translation are different (Chen et al.,
resubmitted to Science). In this proposed research, I will further adapt and apply this novel technology to (i)
identify and characterize the sequence and protein components that regulate circRNA translation specifically, (ii)
identify the association between genetic variation, circRNA translation, and disease, (iii) characterize circRNA
translation in a tissue-dependent manner systematically, and (iv) build a non-integrative and stable gene
expression platform with tunable expression level and tissue specificity. This proposed research will build the
foundation of my future research as an independent researcher to investigate the regulation and the coordination
between different translation machinery (cap-dependent vs. independent translation) among different RNA
species (linear vs. circular RNAs).
This work will be performed under the mentorship of Dr. Howard Chang at the Stanford University School
of Medicine, an expert in technology development and RNA biology who has highly-successful track records of
placing postdoctoral fellows into independent academic positions at leading institutions. Further training in
scientific and professional skills will be achieved by utilizing the resources available through the Stanford
University School of Medicine and the Office of Postdoctoral Affairs, which provide an outstanding intellectually-
stimulating environment with all facilities and resources necessary for success. All proposed training will
complement my previous training in RNA biology, technology development, and computer programming and
facilitate my transition to an independent researcher, investigating the functions, regulations and clinical
implications of circRNA.

Public health relevance
PROJECT NARRATIVE The human genome encodes tens of thousands of circular RNAs (circRNAs), of which the translation is essential for regulating important biological functions, such as cell proliferation, differentiation, and migration. Current technologies cannot distinguish circRNAs from linear RNAs efficiently, such that the mechanism and molecular components regulating circRNA translation remain unclear. The proposed research will utilize my newly developed technology, which can identify the RNA sequences that initiate circRNA translation specifically, to (i) characterize the sequence and protein components regulating circRNA translation, (ii) elucidate the association between genetic variation, circRNA translation and disease, and (iii) build a gene expression platform with tunable expression level and tissue specificity.